Rapid-Prototyping and Design Core

PROJECT SUMMARY
The major goal of the Rapid-Prototyping and Design Core (RPDC) remains to support the user's needs for the
design of new unique research equipment. Additional goals for the RPDC is the education and training of
users, empowering them to participate in the manufacturing, construction, maintenance, and upgrading of their
unique research equipment designs.

Public health relevance
PROJECT NARRATIVE The goal of the RPDC is the education and training of users and empowering them to participate in the manufacturing, construction, maintenance, and upgrading of their unique research equipment designs.